Core A: Administrative Core

Core A - Administrative Core: Project Summary / Abstract
The Administrative Core is responsible for leadership and management of the Genetics and Genomics of
Leiomyosarcoma (LMS): Improved understanding of cancer biology and new approaches to diagnosis and
treatment SPORE. The leadership of this Core addresses challenges and opportunities arising in the SPORE
weekly webinars, in-person group meetings and ongoing progress reports. The aim is to ensure Project co-
leaders and their investigators are making progress in achieving their aims and that the Cores are providing the
needed support to ensure overall translational goals are achieved. The Administrative Core will oversee the
Career Enhancement (CEP) and Developmental Research (DRP) Programs, by establishing expectations and
helping overcome challenges, such that these programs fulfill their vital missions to implement effective plans to
recruit early career investigators and identify promising, innovative developmental projects. Core leadership will
be responsible for coordinating the External Advisory Board (EAB) meetings and calls as needed to ensure the
EAB is kept informed of progress as well as any challenges requiring their advice.
Leiomyosarcoma (LMS) provides an ideal opportunity for a collaborative SPORE program that brings together
exceptional laboratory and clinical translational scientists with the collective goal of better understanding
leiomyosarcoma and improving treatment. This work will have broader relevance to other sarcoma sub-types
including undifferentiated pleomorphic sarcoma and osteosarcoma. The team assembled for this grant has been
working together on LMS focused research with philanthropic support for the past 3 years. The Principal
Investigators and Core Co-Director have worked together over the past 18+ years on collaborative research
projects at the University of Michigan and within an academic research consortium. As leaders in the research
consortium, Dr. Baker, Dr. Schuetze and Ms. Reinke have the skills and understanding of what is needed to
bring a multi-institutional team together and facilitate collaborative research successfully. The leadership team
will be administratively supported by the grant management infrastructure at the University of Michigan Medical
School which effectively manages NIH grant funding not only at the University but across collaborative academic
institutions, a structure aligned with the organization of this grant.
The SPORE investigators are aware of the challenges, resource requirements and potential pitfalls relevant to
the conduct of this collaborative research and these challenges are mitigated by engaging the well-established
collaborative infrastructure of this team. We have created a flexible, highly interactive Administrative Core
whereby research plans are collaboratively developed, progress is rigorously monitored, and adjustments are
rapidly implemented so as to realize the SPORE goals of improved sarcoma patient care and outcomes.